Development of Safe and Rapid Reporter Viruses for Studying Pathogenic and Pandemic Viruses

ABSTRACT
Neutralizing titer is a demonstrated correlate of protection across most viral pathogens. The traditional assay to
assess neutralization titer is the plaque reduction neutralization test (PRNT), which is generally regarded as
slow, subjective, and variable. To conduct large scale clinical vaccine trials, thousands of serum samples from
vaccinated individuals are typically assessed in neutralization assays, a scale that is difficult to achieve using
live virus in high containment facilities. Optical reporters such as GFP and luciferase encoded in ‘reporter
viruses’ are an alternative to PRNT and are more streamlined, safe, and scalable than PRNT assays but still
require a week of experimentation. Here we propose to develop a Rapid Reporter Virus (RRV) to assess virus
infection and neutralization rapidly and safely. The development of this novel assay is in direct response to our
customers’ requests for a better neutralization readout.

Public health relevance
PROJECT NARRATIVE This proposal will contribute to public health and the cure of disease by creating a transformative technology for testing the neutralizing capacity of sera and antibodies, increasing laboratory throughput by 10-fold and dramatically expanding the number of laboratories that can safely perform viral neutralization assays. The proposed assays would impact the capabilities and capacity of clinical labs at both full-service CROs and large vaccine developers, as well as pandemic preparedness being coordinated by the NIH, BARDA, and academic laboratories.